Community Liason and Recruitment Core

REVISED ABSTRACT: The public health impact of interventions is often not realized because stakeholders have not been involved in the development of preventive strategies or interventions intended for them. Johns Hopkins researchers have been at the forefront of Community-Based Research methods for over a decade.4-9 As an approach, CBPR promotes community-academic partnerships in which community members and/or recipients of interventions are involved in all phases of research, including (1) identifying the health issues of concern to communities; (2) developing assessment tools; (3) collecting, analyzing, and interpreting data; (4) determining how data can be used to inform actions to improve community health; (5) creating the research designs; (6) designing, implementing, and evaluating interventions; and (7) disseminating findings. The overarching goal of the Community-Liaison and Recruitment Core (CLRC) is to communicate and collaborate with community organizations to increase the translation of the preventive strategies and interventions that are developed. Developing and sustaining community partners, as well as training and engaging JHAD-RCMAR Scientists in community-engaged research will reflect collaborative and synergistic work with other JHAD-RCMAR Cores. Specifically, the CLRC will work with the Leadership and Administrative Core to develop collaborative relationships with communities of faith, and community-based organizations as partners in designing interventions to ameliorate variations across groups in cognitive impairment and ADRD in older adults from different social and economic groups; and identify and develop appropriate mechanisms for disseminating information about AD/ADRD and about related research results. The CLRC will also be guided by the Research Education Component to establish new or adapt evidence-based intervention models that embrace community participation and future trial results for older persons from different social and economic groups; train RCMAR scientists, investigators, and lay consumers about community-engaged research, including the ethical dimensions; and develop the JHAD-RCMAR Outreach Initiative. In addition, the CLRC will collaborate with the Analysis Core to enhance the capacity of representatives of community-based organizations, faith communities, and primary care practitioners to participate in research as partners in inquiry; and study recruitment and retention of older participants in ADRD-relevant research, particularly older adults from different social and economic groups. By blending features of ‘clinical’ and ‘community’ approaches, we can better address variations in health across groups and have a significant public health impact on the health and well-being of an aging population.